FREEDOM-HIV

Advances in treatment and care have transitioned HIV from a fatal to a chronic disease. Primary health
concerns of this population have accordingly transitioned to co-occurring chronic diseases like T2DM and their
interaction with HIV treatment. The highest rates of T2DM are found in Deep South states and
disproportionately burden Black Americans. Additionally, while only 13% of the U.S. population, Black
Americans account for 43% of new HIV diagnoses. Like T2DM, these disparities are most pronounced in the
South, where over half of new HIV diagnoses occur. Over half of the racial health disparities related to T2DM
and HIV can be attributed to social determinants of health (SDoH), including reduced healthcare access,
poverty, transportation barriers, and food insecurity. There is a need for effective and sustainable intervention
packages that address T2DM-related outcomes and improve health equity for people living with HIV (PWH).
This is critical since people on HIV treatment have poor glycemic outcomes, which can also hinder the HIV
treatment adherence. The overall goal of the Food Delivery, Remote Monitoring, and Coaching-Enhanced
EDucation for Optimized Diabetes Management for People Living with HIV (FREEDOM-HIV) study is to
develop an optimized, multilevel, and scalable intervention to improve T2DM control in low-income Black adults
with HIV and T2DM in the Deep South by targeting relevant SDoH. The FREEDOM-HIV study will enroll 80
Black adults with suboptimal SDoH through three health systems in AL and MS. A randomized factorial
optimization design using a multiphase optimization strategy (MOST) will evaluate three intervention
components: 1) digital health coaching, 2) food box delivery, and 3) remote patient monitoring (RPM). Thus,
this project will evaluate multilevel interventions that address changes at the levels of individual (patient),
interpersonal (patientcare team communication), organizational (healthcare system-delivered RPM), and
community (food box delivery) to improve T2DM management among socially vulnerable Black adults with HIV
and T2DM. Aim 1 will identify the combination(s) of the three intervention components that reduce HbA1c
(primary outcome) at 12 months. Aim 2 will identify contextual factors that impact implementation of these
different interventions using a Consolidated Framework for Implementation (CFIR) approach, and the
implementation outcomes will be assessed via the Reach, Effectiveness, Adoption, Implementation, and
Maintenance (RE-AIM) framework. This study will leverage multi-healthcare system and healthcare system–
industry partnerships from our parent project FREEDOM to develop optimized, sustainable intervention
strategies to improve T2DM outcomes in socially vulnerable Black adults living with HIV in the Deep South.

Public health relevance
The overall goal of the Food Delivery, Remote Monitoring, and Coaching-Enhanced EDucation for Optimized Diabetes Management (FREEDOM) study (Project 3; P50MD017338) is to develop an optimized, multilevel, and scalable intervention to improve T2DM control in low- income Black adults with T2DM and cardiorenal complications in the Deep South by targeting relevant SDoH. FREEDOM-HIV will expand upon the FREEDOM study to enroll people with T2DM and HIV. This study will leverage multi-healthcare system and healthcare system– industry partnerships to develop optimized, sustainable intervention strategies to improve T2DM outcomes in socially vulnerable Black adults living with HIV in the Deep South.